Chemoprevention and mechanisms of obesity-promoted pancreatic adenocarcinoma

PROJECT SUMMARY
The Program Project Grant “Chemoprevention and mechanisms of obesity-promoted pancreatic
adenocarcinoma” constitutes a highly collaborative, multidisciplinary research program designed to make a
significant impact on the investigation of obesity in the development of pancreatic cancer. A detailed
understanding of the biological mechanisms of action of obesity on pancreatic cancer development can form the
rationale for biologically-based practices, scientifically-founded recommendations and interventional strategies
in the prevention of this disease. The Program Project includes expertise from the UCLA campus and Cedars
Sinai Medical Center. The Program is led by experienced pancreatic cancer researchers, who have organized
investigative teams to develop highly interactive and synergistic research programs. The goal is to study the
mechanisms, by which obesity promotes pancreatic cancer development and to explore interventional, cancer-
preventing strategies. Innovative animal and cell culture models and novel concepts strongly supported by a
wealth of preliminary data are proposed. The Projects will focus on: Adipose tissue inflammation in obesity-
promoted pancreatic cancer (Project 1); Chemoprevention of pancreatic cancer with lipid-lowering and
antidiabetic agents (Project 2); Role of the pancreatic fibro-inflammatory microenvironment in obesity-
promoted pancreatic cancer (Project 3). The projects will utilize an Administrative Core (with Biostatistics Sub-
Core) and a Shared Resource Core, the Animal and Cell Models Core (with Pathology Sub-Core). An External
Advisory Board comprised of nationally and internationally recognized translational pancreatic cancer
investigators and advocates has been assembled. The Program Project is designed for maximum integration
and synergy of research and key investigators, who have been collaborating for more than 12 years so that the
proposed Program can be focused on the most promising investigations with the greatest translational potential
and impact.

Public health relevance
PROJECT NARRATIVE This Program Project Grant is designed to investigate the effects of obesity on pancreatic cancer development and to evaluate potentially preventive/interceptive strategies. The Program consists of three highly synergistic and integrative Projects, which are led by experienced pancreatic cancer researchers with proven track record of successful collaboration for more than 12 years. The Projects are supported by an Administrative Core and one Shared Resource Core (Animal and Cell Model Core).